Training in HIV Implementation Science and Dissemination in Kenya

Project Summary/Abstract
This training program will develop research capacity in HIV Implementation Science and Dissemination by
leveraging a long-standing collaboration between Moi University College of Health Sciences (Moi University
School of Public Health [MUSPH] and School of Medicine [MUSM]) in Kenya and the Academic Model
Providing Access to Healthcare (AMPATH) Consortium, a collaboration of North American and European
Universities led by Indiana University. The over-arching aim of this proposal is to create sustainable and
collaborative capacity for HIV Implementation Science and Dissemination (HIV-ID) both within academia and at
the county-level (equivalent to U.S. states). The primary aim is to build a sustainable educational infrastructure
to support training in HIV-ID in western Kenya. This will be achieved by enhancing existing degree programs
and supporting establishment of emerging degree programs at MUSPH. The second aim is to expand human
resource capacity in HIV-ID that promotes collaboration between academia and county health teams. This will
be accomplished by supporting training for 12 masters and two doctoral students, including six masters
students representing county health teams. The third aim is to support continuation of trainees in HIV-ID. This
will be accomplished by establishing a competitive post-graduate fellowship program to conduct research
embedded in county health teams and by training 5 post-graduate fellows within this program.
We will build research mentorship capacity at MUCHS by leveraging a collaboratively developed mentorship
training program and creating an environment where mentorship modeling and growth is promoted. We will
engage county health teams and county governments in the HIV-ID Program to address the vital need for their
collaboration with academics in order to tackle challenges within the HIV prevention and care cascades. This
will be addressed by strengthening existing relationships with the counties, supporting masters students from
the counties, opening program workshops to county health teams, and promoting research projects that
engage county health teams. We will promote reciprocal innovation, defined as the bidirectional, co-
constituted, and iterative exchange of ideas, resources, and innovations to address shared health challenges
across diverse global settings. This will be achieved by supporting collaborative Kenyan and North American
trainee mentorship and by creating and supporting a joint learning process for Kenyan and U.S. post-graduate
fellows.
By strengthening in-country educational infrastructure, expanding local human resource capacity in strategic
areas, promoting sustained engagement in research, enhancing mentorship capacity, and supporting research
collaboration with county health teams, this training program will build sustainable research capacity for HIV-ID
and promote decolonization of global health.

Public health relevance
Project Narrative As of 2021, Kenya was the home of approximately 1.4 million people living with HIV (PLVHIV) and ranked eighth globally for the highest number of PLHIV residing within a country. Given this burden of disease, it is imperative that Kenyan investigators have the training to recognize gaps in the HIV prevention and care cascades, design implementation strategies to address those gaps, assess the effectiveness of these strategies, and translate findings into best practices to disseminate. By strengthening in-country educational infrastructure, expanding local human resource capacity in strategic areas, promoting sustained engagement in research, enhancing mentorship capacity, and supporting research collaboration with county health teams, this training program will build sustainable research capacity for HIV Implementation Science and Dissemination Research (HIV-ID) and promote decolonization of global health.